COLLECTION, PRESERVATION &TRANSFUSION OF NEUTROPHILS

This project is directed to understanding the physiologic regulation of neutro-phil production and function and the potential clinical uses of hematopoietic growth factors and glucocorticosteroids in the treatment of hematological and infectious diseases.